Epigenetic Regulation of Retinal Regeneration

SUMMARY: In fish and amphibians the retina is able to fully regenerate from a variety of insults but this ability
is progressively lost in higher vertebrates, with modest regeneration in birds, and essentially no regeneration in
mammals. Müller glia (MG) are responsible for retinal regeneration and due to the remarkable regenerative
capacity of zebrafish, many studies have used this model to uncover the molecular underpinnings of retinal
regeneration. In zebrafish, retinal damage first stimulates MG to adopt a gliotic state, but this is transient and
they subsequently reprogram into a stem cell-like state, re-enter the cell cycle and generate multipotent
neurogenic progenitors that then give rise to new neurons. In mammals, including humans, the initial MG gliotic
response to damage is similar to that in zebrafish, but MG fail to reprogram or generate new neurons. Instead,
gliotic responses persist and MG proliferate and eventually form a glial scar. Recent studies have demonstrated
that ectopic expression of a key pro-regenerative gene identified in zebrafish, ascl1, in MG of the adult mouse
retina, along with inhibition of histone deactylase (Hdac) activity, stimulates a MG regenerative response.
Regeneration correlated with increased chromatin accessibility at critical pro-regenerative loci and when
combined with other published studies, suggest that the epigenetic landscape regulating the expression of pro-
regenerative genes during the injury and regenerative responses is a key regulator of the ability of MG to
reprogram and stimulate regeneration. Our knowledge of the epigenetic regulation of retinal regeneration is
limited and this is a critical knowledge gap in the field. Indeed, given that regenerative responses can be
stimulated from normally non-regenerative MG in the mammalian eye, understanding the epigenetic regulation
of retinal regeneration could be transformational in supporting the development of new therapeutics aimed at
restoring neurons lost to retinal degenerative diseases and retinal injuries. We have focused on the epigenetic
regulation of retinal regeneration, using the zebrafish MG reprogramming and regeneration model. We have
generated strong preliminary data supporting a critical role for Brd proteins during MG-dependent retinal
regeneration and more specifically, a role for Brd4 during MG reprogramming. We have identified genes
regulated by Brd activity and developed and validated novel transgenic tools for manipulating Brd activity and
Brd-dependent gene function in MG with spatial and temporal precision. We hypothesize that Brd-mediated
regulation of gene expression in MG is a key regulator of MG reprogramming and MG-dependent retinal
regeneration. Experiments in this proposal test this hypothesis by determining the roles of specific brd proteins
during MG-dependent retinal regeneration and identifying the gene regulatory networks in which they function.
When completed, the results of this study will be of high impact in identifying and validating Brd-dependent genes
that could be useful on their own in stimulating reprogramming or regenerative responses from mammalian MG
or, in combination with other factors, enhance reprogramming and regenerative responses from mammalian MG.

Public health relevance
NARRATIVE: This study seeks to identify key regulators of retinal injury and regenerative responses and the gene expression programs that they control. If successful, these regulators could be leveraged to stimulate regenerative responses in the human retina which would be transformational for the treatment of retinal degenerative diseases and cell loss due to retinal injury.